Pathways underlying kidney vulnerability in outdoor workers

PROJECT SUMMARY
Chronic kidney disease (CKD) is a leading cause of death worldwide. While traditionally associated with older
age, hypertension, diabetes and obesity, a new CKD has emerged characterized by occupational origins and a
nontraditional, multifactorial etiology. This CKD of nontraditional causes (CKDnt) already accounts for nearly 26
million cases of CKD worldwide. Despite often being attributed to concomitant factors like toxin, disease, and
other environmental exposures, evidence supports that CKDnt is associated with work-related heat stress
(WRHS) and the development of hyperthermia- (i.e., increased core (internal) body temperature).
Hyperthermia exposure can cause clinical or subclinical acute kidney injury (AKI). Clinical AKI or repeated
episodes of subclinical AKI (sAKI), defined as increases in AKI biomarkers, leads to a sustained fall in kidney
function. Widespread acceptance of this hyperthermia-mediated etiological pathway is complicated by three
factors. First, studies have largely been conducted in tropical occupational locations with limited seasonal
temperature variation and in workforces mostly free of traditional CKD risk factors. Second, while clinical AKI is
a likely cause of CKDnt, the role of sAKI is less certain. Third, hyperthermia appears to be common in workers
at risk of CKDnt, but the role of repeated hyperthermia exposures is not well understood. Thus, the long-term
goal of this research is to identify solutions that safeguard kidney health during WRHS. The objective of the
proposed project is to identify the contribution of hyperthermia exposure to sAKI and CKDnt risk in a climate
region with seasonal WRHS and in workers with a relatively high prevalence of traditional CKD risk factors.
The central hypothesis is that hyperthermia exposure is a primary driver leading to increased sAKI risk and
sustained declines in kidney function among outdoor workers. The central hypothesis will be tested by
pursuing three independent specific aims in a project that will employ a longitudinal observational design in
which markers of WRHS, hyperthermia exposure, sAKI risk, kidney function, and urinary metabolomic changes
will be measured in the winter and late summer months in construction workers at high risk of WRHS
associated AKI in the U.S. Aim 1 will identify the role of hyperthermia exposure on cross-shift sAKI risk. Aim 2
will characterize longitudinal changes in kidney function over the U.S. summer. Aim 3 will determine changes in
the urinary metabolome in outdoor workers experiencing increased cross-shift sAKI risk. The proposed
research is innovative because it will improve the hyperthermia-mediated sAKI-to-CKDnt model by including
more varied climatic regions and CKD risk factors. This contribution is significant because the obtained
information will provide strong support for a universal hyperthermia-mediated sAKI-to-CKDnt etiology and pave
the way for therapies targeting metabolic pathways to prevent hyperthermia-mediated sAKI and, ultimately,
CKDnt. It is expected that this contribution will provide the foundation for protecting outdoor workers against
sAKI and CKDnt against a backdrop of increasingly hot global temperatures due to climate change.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it aims to understand and inform the identification of solutions that alleviate the risk of subclinical acute kidney injury and chronic kidney disease of nontraditional causes, common and growing health risks caused by occupational heat stress. There is the potential for such information to enhance occupational and public health practices that will protect outdoor workers from subclinical acute kidney injury and chronic kidney disease. Thus, the proposed research is relevant to the part of the NIH and NIDDK's mission that pertains to improving health and enhancing quality of life, particularly as it relates to kidney diseases.